Sodium Nitrite Supplementation for Improving Physiological Function in Patients with Chronic Kidney Disease

CANDIDATE: Matthew J. Rossman, Ph.D., is a postdoctoral fellow training in the integrative physiology of
aging at the University of Colorado (CU) Boulder. In this K01 application, Dr. Rossman aims to determine
the efficacy of a novel nitric oxide (NO) boosting compound, sodium nitrite, for improving vascular, motor
(physical) and cognitive function in patients with chronic kidney disease (CKD). His immediate goal is to
acquire the research training and professional skills necessary to transition to an independent, extramurally
funded investigator. His long-­term goal is to establish his own research program with a focus on identifying
novel, evidence-­based lifestyle and pharmacological interventions that prevent or delay the development of
vascular, motor and cognitive dysfunction to reduce the risk of CVD and other comorbidities in CKD. CAREER
DEVELOPMENT PLAN: Dr. Rossman’s career development plan consists of: 1) acquiring new research
skills associated with the proposed research plan;; 2) training in renal physiology, CKD, motor and cognitive
function, clinical trials and biostatistics through coursework and meetings with his mentorship team;; and 3)
professional skill development through coursework;; attendance/presentations at weekly journal clubs, CU
seminars and national scientific meetings;; and regular interactions with his mentor team. ENVIRONMENT:
The environment for Dr. Rossman’s training plan will be outstanding. Dr. Rossman’s primary mentor Dr.
Douglas Seals and his co-­mentor Dr. Michel Chonchol are internationally recognized, NIH funded scientists
with strong records of successful mentoring in translational biomedical research pertaining to age-­ and
disease-­related physiological dysfunction and CKD. Dr. Chonchol is also a board-­certified nephrologist and
Director of Clinical Research in the Division of Renal Diseases and Hypertension at CU Denver. Consulting
mentor Dr. McQueen is director of biostatistics at the CU Boulder Clinical & Translational Research Center and
regularly provides mentoring/consulting to trainees and faculty conducting clinical trials. Consulting mentor Dr.
Tamura is an associate professor at Stanford University with extensive experience assessing motor and
cognitive function in patients with CKD. Consulting mentor Dr. Bryan is an expert in nitrite/NO biology and
improving physiological function via nitrite supplementation. RESEARCH: CKD is a highly prevalent condition
and CVD is the leading cause of death in patients with CKD. Increased CVD risk in CKD is largely attributable
to the development of vascular dysfunction, primarily vascular endothelial dysfunction and large elastic artery
stiffening. Reduced motor and cognitive function are also common in CKD and increase the risk of disability
and mortality in these patients. Vascular, motor and cognitive dysfunction all are related to reduced NO
bioavailability. Nitrite is a cytoprotective molecule and major storage form of NO with therapeutic potential for
improving multiple domains of physiological dysfunction in CKD. The proposed research will test the efficacy of
oral sodium nitrite therapy for improving vascular, motor and cognitive function in patients with CKD.

Public health relevance
PROJECT NARRATIVE Nitric oxide (NO) is an essential molecule in the body that is decreased in patients with chronic kidney disease (CKD), leading to reductions in vascular, movement (“motor”) and cognitive functions. This study will determine if daily oral supplementation (6 months) with a compound that increases NO in the body, i.e., sodium nitrite, improves vascular, motor and cognitive function in patients with CKD; this study will also provide insight into the biological reasons (mechanisms) by which supplementation with sodium nitrite improves vascular function in these patients. Overall, this research will provide scientific evidence supporting the use of sodium nitrite for preserving physiological function and preventing comorbid clinical conditions and disability in CKD.